PROPHYLACTIC PENICILLIN IN SICKLE CELL DISEASE

The specific objective of this contract is to evaluate the risks, if any, of discontinuing daily oral penicillin at the age of five years in children with sickle cell disease.